Sex and Race/Ethnicity-specific Multilevel Factors Influencing Pubertal Trajectories: a Population-based Study

ABSTRACT
Age of pubertal onset has declined dramatically in both girls and boys in the US, with substantial racial/ethnic
disparities. This has important public health implications as early puberty is linked with a variety of detrimental
adolescent behavioral and emotional outcomes as well as adult chronic diseases. In response to these trends,
clinicians have adjusted by shifting the guidelines for the cutoff point for early puberty from age <8 to as early
as age <6 in girls. To design effective interventions, we must first: (1) establish current normative trajectories
for US adolescents by sex, race/ethnicity and BMI to reliably identify children who are going through puberty
substantially earlier than their peers of the same racial/ethnic group, and (2) identify sex-specific modifiable risk
factors that can serve as targets for intervention strategies in high-risk groups. Healthy People 2020
emphasizes the importance of improving adolescent health because puberty is an important window of
susceptibility that impacts adolescent behaviors and adult morbidity. To address the lack of data on pubertal
trajectories by racial/ethnic groups, described in PA-18-033, we will take advantage of the robust data for the
racially/ethnically diverse population of Kaiser Permanente Northern California (KPNC) to conduct the largest
population-based, longitudinal study undertaken to date. Acknowledging the importance of screening for early
puberty, KPNC began routine documentation of pediatrician-assessed Tanner stages in the electronic health
record (EHR) in 2010, and we have since validated the quality of these data. We will use these pubertal
development data, race/ethnicity, and pre-pubertal BMI data to efficiently characterize the sex- and
race/ethnicity specific normative distributions of pubertal onset and tempo (rate of pubertal progression from
onset to completion of maturation) in 170,000 boys and girls (Aim 1). We will then use data on a sub-cohort of
boys and girls who were born at KPNC after the implementation of the EHR system (2006) to create a virtual
birth cohort to investigate individual-level early life intervenable metabolic factors such as maternal pre-
pregnancy obesity, gestational weight gain, and postnatal growth trajectory (Aim 2) as factors influencing
pubertal timing. Lastly, we will link historical geocoded address data to the California Neighborhood Data
System, which we developed, to investigate contextual factors (e.g., social and built environment) influencing
pubertal timing (Aim 3). Our studies incorporate several innovations and strengths including the use of large
and comprehensive EHR and a diverse population of boys and girls to conduct an otherwise costly longitudinal
study, examination of several important hallmarks of puberty, and investigation of individual and contextual
level factors as risk factors. Risk factors identified from this study and the role of sex and race/ethnicity will
guide the design of upstream individual- as well as policy-level interventions. Such interventions targeting high
risk groups will advance our long-term goal of preventing health disparities worsened by early puberty.

Public health relevance
PUBLIC HEALTH RELEVANCE STATEMENT Early puberty has been found to increase the risk of depression and behavioral difficulties during adolescence, and of several chronic diseases in adulthood. Despite the observed trend toward earlier pubertal development in US adolescents, little is known about current normative pubertal timing among minorities or boys, nor modifiable risk factors that may influence timing of puberty, aside from childhood obesity. We will characterize normative distributions of pubertal timing in a large representative population so that clinicians can reliably identify children developing substantially earlier than their peers (Aim 1), and further, identify individual-level and neighborhood level factors that influence pubertal timing to inform the design of targeted strategies to prevent early puberty (Aims 2&3), with a long-term goal of reducing adolescent and adult risks of serious chronic diseases.